Investigating Peripheral Neuropathy in Spinocerebellar Ataxia Type 3

ABSTRACT
Spinocerebellar ataxia type 3 (SCA3) is the most common dominantly inherited ataxia and currently has no
effective treatment. This progressive, multisystem disorder is typified by the degeneration of critical parts of the
central nervous system including the cerebellum, brainstem, basal ganglia, and spinal cord. Moreover,
neuropathological studies show widespread involvement of the peripheral nervous system (PNS). Despite the
focus of past research on the central nervous system, peripheral neuropathy symptoms are prominently
observed in over half of SCA3 patients. This research aims to deeply understand SCA3 disease, particularly
exploring its impact on the PNS and its connection to peripheral neuropathy. Our preliminary data in two SCA3
mouse models confirm that both exhibit peripheral neuropathy that mirrors human features. Postmortem tissue
analysis and preliminary SCA3 mouse studies point towards the dysregulation of selective subtypes of dorsal
root ganglion sensory neurons and demyelination as potential instigators of peripheral neuropathy onset in
SCA3 patients. This research employs SCA3 mouse models to analyze peripheral neuropathy onset and
progression through functional, histological, and transcriptional studies. Ultimately, our research aims to
illuminate a cell-type specific mechanistic understanding of SCA3 peripheral neuropathy, paving the way for
potential therapeutic interventions in this crucial area that might have implications for other multisystem
neurodegenerative disorders.

Public health relevance
PROJECT NARRATIVE Spinocerebellar ataxia type 3 (SCA3), the most common dominantly inherited ataxia, typically causes uncoordinated movement, swallowing difficulties, and gait abnormalities. However, more than half of individuals with SCA3 also exhibit peripheral neuropathy symptoms like reduced sensation or burning pains in their distal limbs, significantly impacting quality of life and contributing to mobility impairments. This research aims to investigate the pathogenesis and progression of peripheral neuropathy in SCA3 mouse models, laying groundwork for future therapies targeting peripheral symptoms of SCA3 and related peripheral neuropathy disorders.